Evaluating the role of T cells in NF1-peripheral nerve sheath tumor (PNST) progression

PROJECT SUMMARY/ABSTRACT
Neurofibromatosis type 1 (NF1) is a cancer predisposition syndrome caused by a mutation in the NF1 tumor
suppressor gene that occurs in 1:3000 live births. Loss of neurofibromin, a GTPase activating protein for p21
RAS, causes hyperactivation of the RAS pathway that leads to the formation of plexiform neurofibromas (PNF)
in up to 50% of individuals with NF1. In the majority of NF1 patients, PNF grow slowly, typically reaching stability
in adulthood. However, a subpopulation of NF1 patients experience progression to atypical neurofibromatous
neoplasm of uncertain biologic potential (ANNUBP) and transform to malignant peripheral nerve sheath tumor
(MPNST). MPNSTs are the leading cause of premature death in NF1 patients with a 5-year survival rate of 20-
50%. Therefore, understanding the molecular and cellular interactions that mediate progression along the
peripheral nerve sheath tumor (PNST) continuum is critical to improving NF1 patient survival. The genetic events
governing neurofibroma progression and malignant transformation have been extensively studied and several
key driver events have been implicated. However, preclinical and natural history studies suggest that these
genetic changes may not fully account for the clinical heterogeneity of PNF and ANNUBP precursor lesions and
their evolution to MPNST. Therefore, I postulate that additional factors either intrinsic to neoplastic Schwann cell
progenitors or within the tumor microenvironment play a critical role in modulating the growth and malignant
potential of neurofibroma. My recent work defining the spatial gene expression profile of human NF1-associated
tumors identified alterations in signatures of immune surveillance, including T cell activation and cytotoxicity,
across the PNST continuum. Anti-tumor T cell response signatures were upregulated in ANNUBP, whereas
precursor lesions that progressed to MPNST were characterized by signatures of T cell exhaustion. Furthermore,
immunofluorescence staining showed that human ANNUBPs were characterized by increased infiltration of
CD4+FOXP3- and CD8+FOXP3- T cells, while FOXP3+ T cells (T regulatory cells) predominated in MPNST. While
the density and functional states of T cells infiltrating the tumor microenvironment are important predictors of
therapeutic response and prognosis in many human cancers, the functional role of distinct T cell subsets in
governing neurofibroma progression to MPNST remains undefined. The objective of this work is to define the T
cell subsets present at various stages of the PNST continuum and investigate their functional role in tumor
progression. I hypothesize that effector CD4 and/or cytotoxic CD8+ T cells are critical in preventing malignant
transformation of PNF and ANNUBP precursors. Ultimately, these studies will advance our understanding of the
functional role of T cell subsets across the PNST continuum and inform future diagnostic and therapeutic
strategies for patients with NF1.

Public health relevance
PROJECT NARRATIVE Neurofibromatosis type 1 (NF1) is a cancer predisposition syndrome that causes the development of benign neurofibromas from Schwann cells throughout the central and peripheral nervous systems. Progression of these benign tumors to malignancy is the leading cause of premature death in persons with NF1 and understanding the molecular and cellular interactions that govern malignant transformation is critical to improving NF1 patient survival. Collectively, these studies will provide key insights into the role of T cells in modulating neurofibroma progression and establish a preclinical rationale for the development of immunomodulatory therapeutic strategies to prevent malignant transformation in at risk individuals.